Study of the IL-33-driven immune cell organization underpinning responses to immune checkpoint blockade cancer therapy

The immune checkpoint blockade cancer therapy (ICB) can greatly prolong survival in responders.
However, significant improvement of the response rate of ICB is in urgent need. We have found that IL33 is
expressed in normal epithelial cells of lining tissues such as lung and skin but drastically down-regulated in high-
grade tumor cells in multiple human carcinomas. These clinical data support the notion that down-regulation of
IL33 is a major mechanism of tumor immune evasion. How IL-33 contributes to responses to current ICB therapy
is not explored. Interestingly, our bioinformatics analysis revealed that the IL33 receptor ST2 mRNA is
upregulated in human tumor tissues after successful PD-1 blockade treatment. Using mouse models, we showed
that the IL33/ST2 signaling was required for therapeutic effect of ICB therapy. In addition, we demonstrated that
IL33 was highly induced in immunogenic murine tumor cells during ICB tumor therapy and tumor-expressed IL33
was required for responses to ICB therapy. Despite these strong evidence supporting an antitumor function of
both endogenous and administered IL33, the underlying molecular and cellular mechanisms are not well
understood. Our preliminary data showed that ICB-induced tumor-expressed IL33 drove conspicuous immune
cell re-organization in the tumor microenvironment (TME). We further demonstrated that the antitumor effect of
IL33 is dependent on DC1 and CD8+ T cells, suggesting their role in anchoring the antitumor effect of IL33.
Interestingly, IL33 also led to accumulation of ST2+ Treg cells in the TME, which might counteract the antitumor
effect of IL33 and maintain an immune equilibrium. We hypothesize that tumor-derived IL33 underpins responses
to ICB tumor immunotherapy through promoting a drastic reorganization of the immune cellular network in the
TME. SA1 Determine how IL33 expression is induced in tumor cells by ICB tumor therapy. SA2. We will define
how IL33 organizes the immune cellular network that mediates responses to ICB tumor therapy. SA3. Determine
the mechanisms how ST2 signaling in regulatory T cells (Tregs) limits antitumor activities of IL33.

Public health relevance
Understanding the immune cellular organization driven by IL33 in the TME open doors to rationale design of novel combinational therapy to meet the pressing clinical need for improvement of responses to current cancer immunotherapy.